DATA COORDINATING CENTER TO PROVIDE SERVICES TO WORK COLLABORATIVELY WITH THE NATIONAL NEUROHIV TISSUE CONSORTIUM CLINICAL SITES TO PROVIDE MANAGEMENT AND DATABASE CAPABILITIES, SCIENTIFIC EXPERTISE,

The National NeuroHIV Tissue Consortium (NNTC), currently funded by NIMH, NINDS, NIDA, and NIA, was originally established in 1998 to collect, store, and distribute samples of central and peripheral nervous system tissue, cerebrospinal fluid, blood, and other organs such as heart, lung, liver, and kidney collected from HIV positive and negative patients, to support researchers around the world who wish to pursue sound research projects and further our knowledge of neuroHIV disorders. In addition to brain banking operations, the clinical sites follow and collect ante-mortem data from an active cohort of HIV positive patients including an extensive neurobehavioral battery including neuropsychological testing and psychiatric assessments, neuromedical evaluation, laboratory results, and fluid sample collection for toxicology and sample banking. The new site contract will include revisions to the existing data collection protocol adding new RDoC assessments, neuroimaging, biomarker testing, and updates to various neurobehavioral battery. Detailed pathological evaluations of brain, spinal cord, and peripheral organs are conducted post-mortem and samples are then banked according to strict established protocols to ensure uniformity across the four clinical sites. The DCC for the NNTC under the current contract is tasked with serving as the central data repository, monitoring site adherence to study protocols and SOPs and providing data management, biostatistical and bioinformatic support to enable the clinical sites to effectively catalogue and maintain specimens and clinical data while also facilitating the sharing of resources with the broader scientific community.

Public health relevance
The public health relevance of this contract includes addressing research gaps in the field of neuroHIV by examining the epidemiological and pathophysiologic mechanisms of HIV-1 associated CNS disease outcomes, persistence of HIV-1 viral reservoirs, viral host and genetic factors, aging related comorbidities, and signaling pathways in addictive substances that modify CNS outcomes. Research generated under this contract may also help with discoveries of novel pre-clinical therapeutic strategies for mitigating CNS complications associated with HIV.